Genetic Analysis of Human Developmental Abnormalities

Genetic studies of structural anomalies in humans help to better understand the underlying basis for normal and abnormal embryological development. We have studied the most common brain anomaly in humans, holoprosencephaly (HPE), a structural defect of the developing forebrain and midface. HPE is a genetically heterogeneous disorder associated with various chromosomal anomalies. Recently, mutations in the human Sonic Hedgehog (SHH) gene, ZIC2, SIX3, TGIF, CYPTO, and GLI2 genes were shown to cause familial and sporadic forms of HPE. Furthermore, anomalies in the cholesterol biosynthesis were found in a genetic syndromes associated with HPE. Thus, other yet unidentified HPE causing genes are postulated to be part of the SHH signaling pathway or are involved in the cholesterol biosynthesis.